Engaging Michigan Communities in Deliberations about Medicaid Priorities

DESCRIPTION (provided by applicant): 1. Engage communities, particularly underserved communities, in informed deliberations about current and potential changes to Medicaid eligibility, coverage, and cost-sharing. Building on community-based research partnerships state-wide, we will convene a Steering Committee including community leaders, researchers, decision makers in private healthplans and the Michigan Department of Community Health (MDCH) and other stakeholders. We will adapt an innovative, award-winning web-based simulation exercise, CHAT (CHoosing All Together, usechat.org) in which individuals and groups make tradeoffs between competing needs for limited resources. Options in Medicaid-CHAT may include variations in covered benefits; out-of-pocket spending; population health and public health programs; rewards for healthy behaviors; and quality improvement activities. We will facilitate deliberations throughout the state, disproportionately sampling medically underserved communities and balancing locale (urban, suburban, rural and remote rural) and sociodemographic characteristics, ensuring inclusion of particular perspectives, e.g., those with chronic illness and those who are or will soon be eligible for Medicaid coverage or dually eligible. 2. Prepare policy briefs describing the views of Michigan citizens about Medicaid eligibility, coverage, and cost-sharing and implications for policy. Communicate Medicaid priorities of communities and the policy implications to state leaders, community leaders, insurers, and other stakeholders. 3. Examine the impact of public engagement on participants' knowledge, attitudes, and priorities, and explore the impact on policy decisions. 4. Evaluate the effect of deliberations including a key element of deliberative procedures - representation.

Public health relevance
PUBLIC HEALTH RELEVANCE: We plan to engage underserved communities in informed deliberations about current and potential changes to Medicaid eligibility, coverage, and cost-sharing. We will examine the impact of engaging in these deliberations on participants knowledge and attitudes and explore the impact on organizational decision making. Results will be used to prepare policy briefs describing the priorities and values of those most affected by changes in Medicaid, and results will inform evaluation and research by the Institute for Healthcare Innovation and Policy.